Pulmonary arteriole occlusion by platelet-neutrophil micro-emboli in Acute Chest Syndrome

Project Summary
Acute chest syndrome (ACS) is a type of acute lung injury and one of the leading causes of mortality in Sickle
Cell Disease (SCD). The etiological mechanism that triggers ACS remains poorly understood. 10-20% of SCD
patients hospitalized with acute systemic painful vaso-occlusive episodes develop ACS within next few days,
suggesting that molecular events surrounding vaso-occlusion contribute to lung injury. This epidemiology also
offers a therapeutic window to halt the development of ACS, provided that targeted therapies are identified. In
the first cycle of R01, we used real time in vivo multi-photon-excitation microscopy to make a novel finding that
ACS in SCD mice is secondary to micro-embolism of precapillary pulmonary arterioles by neutrophil-platelet
aggregates. These findings have been published in AJRCCM 2019, JCI-Insight 2017 & 2020, Blood Advances
2017 & 2020, Experimental Hematology 2020, Blood 2020 and Haematologica 2015. We found that platelet P-
selectin contributed to formation of these micro-embolic cellular aggregates and P-selectin inhibition reduced
lung vaso-occlusion by ~50%. Supporting the relevance of our mouse model, recent clinical trial reported ~50%
reduction in pain episodes in SCD patients given P-selectin Ab therapy. In the present renewal of our 5-year
R01, we identify additional P-selectin-independent pathological inflammatory signaling events that can be
targeted to further inhibit lung vaso-occlusion and ACS in SCD. Based on our new preliminary findings, we
hypothesize that liver-derived circulating-fragments of neutrophil extracellular traps (cNETs) arrive in the lung to
promote neutrophil-platelet aggregate-enabled pulmonary arteriole micro-embolism in SCD. We also propose
that inhibiting pore forming protein gasdermin-D (GSDMD)-dependent signaling in neutrophils prevents cNETs
generation and development of ACS. We will test this hypothesis using our newly developed model of
intravenous hemoglobin induced ACS in SCD mice, in vivo imaging of lung in live mice, in vitro microfluidic
studies with patient blood, and SCD mice genetically deficient in GSDMD or platelet-P-selectin. In Aim 1, we will
determine whether SCD mice genetically deficient in platelet-P-selectin are only partially protected from
pulmonary arteriole micro-embolism and ACS. In Aim 2, we will determine whether cNETs shed in the liver, travel
to the lung to promote P-selectin-independent pulmonary arteriole micro-embolism in SCD. In Aim 3, we will
determine whether caspase-4/11-dependent activation of neutrophil-GSDMD promotes shedding of cNETs and
development of ACS in SCD. These studies will introduce a novel paradigm that translocation of DAMPs from
liver to lung promotes lung injury in SCD, and also identify a new GSDMD-mediated, P-selectin-independent
mechanism of ACS in SCD.

Public health relevance
Project Narrative Sickle Cell Disease (SCD) is a genetically inherited disease that affects 100,000 Americans and millions world- wide. Acute chest syndrome (ACS) is a type of lung injury and one of the leading causes of hospitalization among SCD patients; however, there is no available treatment to prevent ACS. We propose to identify new molecular targets that can be blocked therapeutically to prevent ACS in SCD patients.